2004 Mechanisms of Toxicity Gordon Research Conference

DESCRIPTION (provided by applicant) Mechanisms of Toxicity Gordon Research Conference, July 25-30,2004, Colby College, Waterville, Maine. The Mechanisms of Toxicity Gordon Research Conference developed (GRC) has developed a rich tradition of excellence in the dissemination and promotion of research in the toxicological sciences. The conference has been held biennially since 1958 and has evolved to become the premier scientific meeting focusing on molecular mechanisms of chemical injury and the pathogenesis of environmental human disease. The Mechanisms of Toxicity GRC has received funding from NIEHS in past years based on the high quality of the program and the significant contributions of the meeting to the advancement of environmental health sciences. The 2004 conference has been organized to include the latest information in the field of toxicology and the impact of novel and emerging technologies in the field. The topics to be covered in the 2004 conference span the spectrum of toxicological responses from the cell surface to the nucleus and include: i) New and Emerging Technologies; ii) Cell Surface and Nuclear Receptor Biology; iii) Modulation of Adhesion Molecules in Response to Injury; iv) Lipid Signaling in Response to Oxidative Stress: Translation from New Concepts; v) Protein Structure and Function; vi) Chromatin Remodeling; vii) Apoptosis and; viii) Crossroads of the Cell Cycle, Tumor Suppressors and DNA Damage and Repair. The program includes internationally recognized leaders and talented new investigators from the United States and abroad. Time has been allotted for junior investigators to present their work in Late Breaking Research and Poster Sessions. Chairs and co-Chairs will stimulate discussion and dialogue scientific to maximize participation and increase interactions among senior and junior investigators, postdoctoral fellows and students. Thus, the 2004 conference is poised to continue its growth as the single leading small conference in toxicology.